EFFECT OF ASPARTAME INGESTION ON PLASMA PHENYLALANINE CONCENTRATIONS

Assessment of the safety and efficacy of aspartame ingestion with meals on plasma phenylalanine concentrations in normal and phenylketonuric adults.